Modulating the immuno-metabolic interplay in liver cancer with cryoablation

ABSTRACT
Systemic therapies for advanced stage cancer use immune checkpoint inhibitors to exploit patient's own
immune system to generate a robust anti-tumor immune response. This approach is successfully applied for
melanoma and lung cancer, but is less effective for hepatocellular carcinoma (HCC) patients. Since most HCC
patients are diagnosed at intermediate or advanced stages when curative treatment options are limited, a novel
immunotherapy driven treatment is highly desirable.
The acidity of the tumor microenvironment driven by hyperglycolytic tumor metabolism represents a key
mechanism of resistance and contribute to immune cell exhaustion, thereby helping cancer cells evade the local
immune response. Our hypothesis is that tumors responding to immunotherapies have detectable features like
normalization of tumor acidity and higher density of immune cells. These parameters, if measured together, can
help predict which patients will respond to immunotherapy and/or understand why some patients do not. Imaging
extracellular pH (pHe) of tumors along with assessing local immune cell recruitment is necessary to better monitor
and guide liver cancer immunotherapies. However, to accurately co-localize the pHe information with the immune
cells, high spatial resolution pHe imaging is needed. The goal of this proposal is to establish high resolution
in vivo pHe imaging in mouse liver to investigate the effect of cryoablation on tumor aggressiveness in
relation to recruitment of local immune cells.
In Aim 1 we will establish and validate a high resolution pHe imaging technique in mouse liver using a
multidrug resistance gene 2 knockout (Mdr2 KO) model of HCC on a cirrhotic background, where the chronic-
inflammation-fibrosis mimics the important stages of liver injury seen in humans. Since repeated freezing of a
tumor triggers release of antigens for an anti-tumor immune response, in Aim 2 we will determine if cryoablation
can modulate the state of tumor's immunogenicity. Thus, cryoablation may provide an in situ immune system
amplification instrument by converting an aggressive immuno-suppressive tumor into a more immuno-permissive
tumor. The working hypothesis is that MRI-guided cryoablation will raise pHe by killing tumor cells, and will
modulate tumor's degree of immunogenicity by releasing antigens. To investigate the effects of cryoablation,
high resolution pHe images will be acquired in Mdr2 KO mice livers 1 day before and 7 days after cryoablation.
We will use mice with multiple liver tumors and cryoablate only one to investigate both target and distal effects.
Histopathology will be used to reveal intratumoral immune cell recruitment of activated T-cells, helper T-cells,
effector T-cells, phagocytes and M2 macrophages. If successful, this approach will allow future investigations of
synergistic anti-tumor effects achieved by combining cryoablation with immune checkpoint inhibitors for improved
immunotherapeutic effects.

Public health relevance
NARRATIVE Recent cancer treatment strategies stimulate patient's own immune system to mount a strong immune response against otherwise immuno-evasive cancer cells, with promising results in various solid tumors, but this approach is inefficient for treatment of liver cancer. Since freezing tumors by cryoablation triggers anti-tumor immune responses, we posit that cryoablation may enhance treatment effects in liver cancer for personalized cancer therapy. We will use a mouse model of liver cancer that mimics the important stages of liver injury seen in humans, and establish a novel combination of immune cell targeting and metabolic imaging to detect the cryoablation-induced modulation of the immuno-metabolic interplay in liver cancer.